Latino Youths Coping with Discrimination: A Multi-Level Investigation in Micro- and Macro-Time

Project Summary
Exposure to discrimination-related stressors (e.g., racial/ethnic discrimination, unfair treatment) continues
to pose a public health challenge to minority populations as a social determinant of health. Although
discrimination-related stressors have been consistently associated with poor mental health outcomes, there is
a critical need to identify mechanisms and malleable risk/protective factors to integrate in the design of
community and clinical interventions. The overall objective of this R01 application is to investigate mediators
and moderators at multiple ecological (individual, family/peer and school/neighborhood levels) and time-scale
(micro- and macro-time) levels in the link between discrimination-related stressors and mental health among
340 Mexican-origin youth. Guided by a socioecological, life course perspective, the proposed project has three
specific aims: (1) determine within-person discrimination-related stressors that impact Mexican-American origin
youth’s mental health outcomes as well as the mechanisms of action at both micro- and macro-time levels; (2)
identify protective factors that could help youth to successfully cope with discrimination-related stressors and the
conditions under which those protective factors work; and (3) elucidate the youth, parent, and neighborhood
risk factors that moderate the link between discrimination-related stressors and mental health in youth.
The project’s long-term goal is to improve the mental health of Mexican-origin youth by reducing the
deleterious effects of racism, “othering,” and negative neighborhood interactions. The central hypothesis is that
this link will be mediated by cognitive and/or affective mechanisms (i.e. anger, hypervigilance, emotion
regulation, low social position as threats to self-worth) and moderated by coping resources (parental
adaptation and racial socialization) and family, peer, and neighborhood supports, thus representing multiple
ecological levels. Community-based collaboration will help ensure recruitment of the targeted sample of
Mexican-origin adolescents, mothers, and fathers; the inclusion of fathers will be a valuable contribution to the
literature, given the dearth of studies on Latinx fathers/stepfathers. Through the innovative integration of both
yearly longitudinal (macro-time) and daily diary (micro-time) research design features, important questions
about how mediating and moderating processes unfold over time will be addressed. The proposed analyses
also reflect the multi-layered sociocultural niches occupied by Latinx adolescents by employing individual-level
methods as well as dyadic (adolescent-mother; adolescent-father) and triadic (adolescent-mother-father)
analyses to test key study hypotheses. Considering the current growth of Latinx immigrants, it is imperative to
test a socioecological model of risk and resilience for Mexican-origin adolescents that is responsive to both
their immediate context and the larger global forces around migration. This research is highly translational in
that it will facilitate the development of more effective, culturally sensitive prevention and intervention strategies
for Latinx youth and their families.

Public health relevance
Project Narrative Few longitudinal studies have explored why and how discrimination-related stressors for Latinx youth, the largest minority group (17.9 million under the age of 18), convey risk for negative mental health outcomes, and the mechanisms leading to or moderating such risk. This revised R01 aims to evaluate specific malleable risk and protective factors at multiple ecological levels so that findings can aid in the development of targeted, culturally sensitive preventive interventions.